INSULIN-THERAPY RESISTANT EPIGENETIC MODIFICATIONS IN DIABETIC RETINOPATHY

Abstract Diabetic retinopathy remains the leading cause of blindness in working age adults. Currently, there are no approved and demonstrated treatments for diabetic retinopathy aside from insulin replacement therapy and blood pressure control. Recent longitudinal study reports have demonstrated that despite achieving stable blood glucose levels and HbA1c control, patients formerly under non-intensive insulin therapy continue to have a higher rate of developing diabetic retinopathy, and other complications. This provides the first large-scale clinical evidence for the hypothesis of metabolic memory, in which a period of poor diabetes management continues to impact development of retinopathy and other complications for years after good control has been achieved. Understanding the role of metabolic memory in complication development is vitally needed as the memory phenomenon is obviously not overcome by current treatment regimens. This clinical phenomenon also leads to the questions of what molecular events occur during poor control and how do these events persist for years after good glycemic control is established. This proposal seeks to address this issue through an investigation of the hypothesis that poor control causes epigenomic changes that are not fully reversed with improved diabetes management. In the proposed studies we will define retinal gene promoter DNA methylation and associated chromatin modifications in the context of diabetes with variable glycemic control. We will then use bioinformatic tools to compare the epigenetic state to retinal gene/protein expression. Epigenetic changes will be confirmed by orthogonal methods and the resulting transcript and protein expression changes will be localized to specific retinal layers and cell types. Lastly the processes that regulate DNA methylation and histone modification will be examined. These studies will serve as the basis for future interventional studies which seek to maintain or return the normal retina epigenetic state as well as mechanistic studies investigating how specific genes are targeted for epigenetic modifications during hyperglycemia.

Public health relevance
Project Narrative Diabetic retinopathy remains the leading cause of blindness in working age adults and recent clinical studies have demonstrated that despite achieving good diabetes control, patients with previously poor diabetes control continue to have a higher rate of developing diabetic retinopathy and other complications. This study will investigate the potential epigenetic basis of this metabolic memory phenomenon. Understanding the role of epigenetic changes in diabetic retinopathy will open new avenues for development of therapies which seek to maintain or restore the pre-diabetic state. __SpecificAimsTextDelimiter__ Specific Aims - Despite advances in diabetes management, diabetic retinopathy (DR) remains the leading cause of blindness in working age adults. With the increasing prevalence of Type II diabetes, especially in juveniles, the incidence of DR is likely to increase. The current standard of care is to delay disease progression through insulin replacement, blood pressure control, and ultimately laser photocoagulation. No current therapies are capable of reversing or preventing DR progression. For a number of years it has been hypothesized that periods of poor glycemic control continue to promote diabetic complications development long after good glycemic control has been restored, and far beyond the point at which glycated hemoglobin has been brought to normal levels. This phenomenon has been termed 'metabolic memory'. Recent reports from the EDIC, DCCT, and UKPDS longitudinal studies provide strong clinical evidence of this phenomenon, suggesting that even after 10 years of intensive insulin therapy, patients previously under non-intensive insulin therapy have a greater risk of complications development. This suggests that molecular or cellular changes occurring during periods of non-intensive/poor control are: 1) not fully normalized by intensive insulin therapy; 2) not reflected in standard clinical measures, such as glycated hemoglobin; and 3) increase the rate of complications development for years after good glycemic control has been achieved. As a regulatory mechanism that can persist for the life of the cell, stable epigenomic modifications may confer a continued risk of complications development long after good glycemic control has been achieved. This proposal seeks to investigate the hypothesis that poor glycemic control causes retinal epigenomic changes that lead to DR and are not fully reversed with good glycemic control. Demonstration of insulin treatment-resistant epigenomic changes in the retina would be the first of its kind and open new avenues for understanding diabetic complications and developing treatments capable of restoring/maintaining the pre-diabetes epigenomic state. Such interventions will be necessary for decades to come, particularly for Type II patients, who often have poor glycemic control for a substantial period of time prior to diagnosis and effective glucose control. Specific Aim 1: Define retinal gene promoter DNA methylation in the context of diabetes with differing histories of glycemic control. This aim will test the hypothesis that diabetes alters the methylation of specific gene promoters and that these changes are not completely normalized by good glycemic control. We will use the STZ-induced Sprague Dawley rat model and a 3 month duration of diabetes, which we have extensively characterized for changes in retinal function and gene expression. Non-diabetic, untreated diabetic (poor control), diabetic treated with insulin for the later 11/2 months of diabetes (poor control - good control), and diabetic treated with insulin for 23 months (good control) will be compared for differences in retinal DNA promoter methylation across the genome (>25,000 genes) using the meDIP-Chip approach. These data will be combined with our existing databases of retinal gene expression to identify which epigenetic changes are correlated to changes in retinal mRNA and protein levels to identify functionally relevant epigenetic alterations. Methylation changes corresponding to differences in gene expression will be confirmed by orthogonal methods (meDIP-qPCR and pyrosequencing) in independent animals. Changes will then be localized to specific retinal cell types. We will also delineate when these changes and the engagement of epigenetic signaling mechanisms (DNA methyltransferase activity and expression) first occur. Specific Aim 2: Define retinal chromatin modifications in the context of diabetes with variable glycemic control. Chromatin modification works in concert with DNA promoter methylation to regulate gene expression. To compliment the promoter DNA methylation analysis, genome-wide examination of promoter- associated histone protein modifications will also be performed using the same animal groups as SA #1. Chromatin immunoprecipitation (ChIP-Chip) analysis will examine transcription-activating [histone 3 lysine 9 acetylation (H3K9ac)] and -repressing signals [histone 3 lysine 9 trimethylation (H3K9me3)] across the genome (>25,000 gene promoters). As in SA #1, changes will be confirmed by orthogonal methods (ChIP- qPCR) in independent animals and localized to specific cell types. We will also determine the duration of hyperglycemia needed to engage chromatin modification signaling mechanisms (histone acetyltransferase and deactylase activity and expression) and their responsiveness to insulin therapy. These studies are designed to overcome a major obstacle to progress in understanding metabolic memory and DR pathogenesis: the lack of knowledge on the extent and duration of retinal epigenomic changes in vivo with hyperglycemia and insulin therapy. These data will serve as the basis for future interventional studies seeking to maintain or restore the normal retinal epigenomic state as an adjuvant to the glycemic control achieved by insulin therapy, as well as investigations of the mechanisms by which hyperglycemia induces epigenetic changes and targets specific genes.